Administrative Core

The Administrative Core provides leadership for the Center for Transformative Community-Driven Research to Prevent Obesity-related Cancer (the Center), including planning, implementation, evaluation and communication support among cores and research projects, community partners and collaborating academic institutions. The Administrative Core will serve as the strategic hub of the Center, connecting with a network of community and academic partners, to address complex social determinants that are the root of cancer disparities in a historically Black, persistent poverty community. The Administrative Core will receive high-level strategic guidance from scientific and community advisory committees, who will provide scientific insight as well as provide a vision for integration of the Center into the Acres Homes community in Houston. The Administrative Core will develop and implement processes for smooth operations across the research projects and cores, for collaborative community outreach, and for general administrative activities such as regulatory oversight, documentation, and formal reporting. The Administrative Core will lead a joint comprehensive planning, priority setting, implementation and evaluation process, which will enable the launch of the Center’s major components. And finally, the Administrative Core will provide leadership to and management of the Center evaluation, which will appraise the Center’s success. The Administrative Core will accomplish this goal through strategic leadership and oversight of the Center, achieving the following specific aims: (1) Provide administrative support, financial management, and logistical support to the cores and projects of the Center and facilitate communication among cores and research projects, community partners, collaborating academic institutions; (2) Connect and integrate the Center in the larger Persistent Poverty Initiative Network; and (3) Oversee planning, implementation, and evaluation activities for the Center.

Public health relevance
The Administrative Core provides leadership, oversight and infrastructure to support all scientific, administrative, and financial activities of the Center for Transformative Community-driven Research to Prevent Obesity-related Cancer (the Center), including the two research projects and the research and methods, career enhancement, developmental, and engagement cores. The Administrative Core will serve as the strategic hub of the Center, facilitating communication and collaboration among the community organizations and academic partners, as well as with members of the Persistent Poverty Initiative Network.